Center for Translational Research in Health Disparities

ABSTRACT
The Morehouse School of Medicine (MSM) vision as detailed in our current Strategic Plan is “leading the creation and
advancement of health equity”. To accomplish this vision, and ultimately health equity, new structures are required. More
rapid translation of research discoveries has been facilitated through a “team-based approach” to address the health of the
people and communities. This means bringing biomedical, clinical, and behavioral investigators and others together in
Multidisciplinary Translational Teams (MDTT’s) focused on a health disparity that bring to bear their combined expertise
to address populations health translating discoveries into practical solutions. MSM RCMI Program has been successful at
developing research infrastructure including researchers. This application has been developed to bring the expertise of the
RCMI Program Cores, with Community and Clinical researchers and partners to build Multidisciplinary Translational
Teams across the T spectrum targeted at more rapid translation of health disparities (e.g., Cancer, Stroke, Infectious
Diseases, Cardiometabolic Disease, Reproductive Health) by expanding the baseline research infrastructure established by
Morehouse School of Medicine. The primary objectives are to build those teams through research projects targeted at
health disparities, and to develop a pipeline of developing research teams at MSM, and to increase the level of
involvement of investigators in conducting MDTT research at MSM. The U54 Center for Translational Research in
Health Disparities (CTRHD) consists of five Cores (Administrative, Research Infrastructure, Investigation Development,
Community Engagement, and Recruitment); Three Research Projects; an evaluation component attached to the
Administrative Core, and a Pilot Project Program attached to the Investigator Development Core. With these assets and
activities, the CTRHD will accomplish its goal through the following Aims:
AIM 1: Transform Our Institution. Build processes and structures facilitating development of competitive
multidisciplinary translational teams (MDTTs), allowing MSM to emerge as the preeminent, research-intensive, minority
serving academic health center in the nation.
AIM 2: Transform the MSM Research Environment. Develop collaborations allowing MSM faculty to do cutting edge
translational health disparities research.
AIM 3: Transform the Community of Scientists. Promote and accelerate training and mentoring capabilities at MSM,
leading to the next generation of leaders in health disparities multidisciplinary translational research.
AIM 4. Transform Our Community. Facilitate integration of Basic Research with Community Engagement.

Public health relevance
The goal of the MSM RCMI U54 Center for Translational Research in Health Disparities (U54/CTRHD) is the rapid translation of health disparities research across the T spectrum through development of Multidisciplinary Translational Teams (MDTT’s).